Intermountain Program on Antibiotic Resistance and microbial Threats (IMPART)

PROJECT SUMMARY
We enthusiastically propose to renew our CDC Prevention Epicenter, entitled “InterMountain Program in
Antibiotic Resistance and microbial Threats (IMPART). Our proposal assembles an exceptional group of
investigators who have an extraordinary capacity to conduct large-scale observational studies, as well as lead
or co-lead interventional studies that range in scope from small pilots to multi-community randomized trials The
University of Utah is the hub for our program, with Intermountain Health, a large regional integrated health
system, serving as a major node. The Veterans Affairs (VA) Salt Lake City Healthcare System is another key
partner for our Prevention Epicenter site, operating within a programmatic network that encompasses the
entire VA health system. The resources that we bring to the CDC Prevention Epicenter Program will be broadly
beneficial to its mission to improve healthcare safety and prevent healthcare-associated infection. We have
accumulated the experience in translational research and expertise in multi-disciplinary methods to make
significant contributions to improve the quality of antibiotic use, combat antibiotic resistance, and enhance
health system response to microbial threats across the continuum of care. Moreover, we have developed a
computational environment to support comprehensive epidemiological analysis of infections within the
Department of Veterans Affairs (VA) Health System, as well as Intermountain Healthcare and University of
Utah Health (UHealth). Our proposed research has a high level of significance for policy-making and
implementation. Core Project 1 evaluates alternative implementation strategies for outpatient stewardship and
advances dissemination of best practices for AS. Core Project 2 tackles a longstanding source of controversy
in the healthcare epidemiology community, namely, the role of active surveillance and contact precautions
(CP) in preventing healthcare-associated infection due to endemic multi-drug resistant organisms (MDRO)
such as methicillin-resistant Staphylococcus aureus (MRSA). A period of partial CP deimplementation in some
VA facilities, triggered in response to the emergence of COVID-19, creates the opportunity to study the impact
of this natural experiment. Core Project 3 links an epidemiological analysis of transmission pathways in LTC
facilities to the development and implementation of novel approaches to improve practice. Core Project 4
confronts the global health challenge of COVID-19, to enhance preparedness for future epidemics and
increase understanding of how to control healthcare spread of both seasonal and novel viruses. We are
committed to active engagement with other Prevention Epicenter sites on collaborative projects and to work
closely with public health entities at national, state, and local levels. We also pledge to contribute to
programmatic domains and pathogen-specific workgroups set up under the auspices of the Prevention
Epicenter Program. For all of our activities, close alignment with the health priorities of CDC will be
established, along with substantial programmatic involvement of CDC staff.

Public health relevance
PROJECT NARRATIVE Our proposed research addresses problems of high importance to public health. Healthcare-associated infection, antibiotic resistance, and emerging pathogens have profound impacts on morbidity and mortality. The research proposed here will lead to better ways to control and respond to these threats to human health.